Functional Genomics of Tibetan Adaptations

ABSTRACT
Although hypoxia is a major stress on human physiology, several populations have adapted to
high altitude (HA) hypoxic environments. Among them, Tibetans have been studied most
extensively and they have been shown to have relatively low hemoglobin (Hb) levels. As a
result, they are severely hypoxemic and how their physiology copes with hypoxia remains poorly
understood. Through a unique combination of genome-wide association studies, tests for
polygenic adaptation and functional in vitro assays, the Di Rienzo lab has made two major
observations: 1) the strongest association signals for Hb and the strongest selective sweep
signals in the genome, found at the EPAS1 locus, influence enhancer activity in endothelial cells
(ECs), and 2) lower pulse was favored by natural selection in Tibetans. These findings raise the
questions of whether and how cardiovascular functions changed in Tibetans as a result of
adaptations to HA hypoxia. To answer them, we propose the following specific aims:
Aim 1. Develop a unique resource for the functional characterization of Tibetan adaptations. We
will generate and genotype lymphoblastoid cell lines for 24 Tibetans (TBC) and will purchase 24
LCLs from Han Chinese (CHB) from the 1000 genome project. These LCLs will be
reprogrammed to induced pluripotent stem cells (iPSCs) and then differentiated in parallel into
cardiomyocytes (CMs) and ECs.
Aim 2. Test the hypothesis that cardiovascular functions were targets of adaptation to hypoxia in
Tibetans. All the CMs and ECs will be cultured in normoxia and hypoxia; RNA-seq data will be
collected and analyzed to identify genes and co-expression modules that differ in the
transcriptional response to hypoxia between TBC and CHB. Cis-regulatory variants that may
account for between-population differences in response to hypoxia will be identified using the
RNA-seq data and, in turn, will be tested for evidence of polygenic adaptations in Tibetans.
Aim 3. Investigate the effects of adaptive alleles by editing iPSCs. We will use editing
technologies to delete 10 enhancers including those at the EPAS1 locus and others identified in
Aim 2. We will replace alleles by precise genome editing. We will also generate transgenic mice
with deletion of EPAS1 enhancer and with the corresponding enhancer alleles in humans.
In summary, we will characterize the mechanisms of cardiovascular adaptations to HA hypoxia
through a unique combination of approaches to elucidate the causal basis of a polygenic
adaptation to an important environmental stressor, in a non-European population.

Public health relevance
NARRATIVE Hypoxia (i.e. low oxygen pressure) is a severe stress with profound effects on a range of physiological systems. Populations adapted to hypoxia, like Tibetans, have emerged as an ideal system for studying the biology of hypoxia. Because the hypoxia experienced at high altitude is similar to that seen in a number of common cardiovascular and respiratory disease, elucidating the mechanisms of tolerance to hypoxia in Tibetans may provide new insights into treatments for these conditions.